Interleukin-1 alpha as a novel treatment for ischemic stroke

PROJECT SUMMARY/ABSTRACT
Stroke is a major cause of death and disability worldwide and more effective therapies are urgently needed.
Unfortunately, all clinical trials that have targeted the primary mechanisms of neuronal injury caused by cerebral
ischemia (CI) (i.e. oxidative stress and excitotoxicity) have failed. CI also induces a potent local inflammatory
response that leads to progressive damage in the ischemic penumbra. However, emerging evidence suggest
that inflammation may also initiate key post-stroke repair processes including angiogenesis leading to long-term
functional recovery. For these reasons we propose that inflammation is an attractive therapeutic target for stroke
recovery. In support of this, we have recently shown that endogenous post-stroke brain upregulation of the
proinflammatory cytokine interleukin-1 (IL-1) isoform IL-1 is tightly regulated in a cell-specific fashion (microglia
acutely and platelets chronically) suggesting that it could play important roles in both injury and repair,
respectively. Furthermore, we now demonstrate that delayed (3 day) post-stroke administration of IL-1
promoted post-stroke angiogenesis in mice. This may occur, at least in part, as the result of IL-1-induced
generation of the proangiogenic extracellular matrix fragment perlecan LG3. Furthermore, as LG3 has known
neuroprotective actions, we hypothesize that IL-1 could be both neuroprotective and neurorestorative in
ischemic stroke. In support of this hypothesis, preliminary results suggest that IL-1 administered systemically
(IV) or intra-arterially (IA) immediately after reperfusion in mice subjected to transient middle cerebral artery
occlusion is well tolerated, profoundly neuroprotective and functionally restorative. Therefore, we hypothesize
that IL-1 may represent a novel neuroprotective agent for ischemic stroke.
To investigate the neuroprotective potential and mechanism(s) of action of IL-1 in experimental ischemic stroke,
we propose the following aims:
Aim 1: Determine the role of acute and chronic endogenous IL-1 in ischemic stroke.
Aim 2: Determine the therapeutic potential of IL-1 in experimental ischemic stroke.
Aim 3: Determine the neuroprotective mechanism(s) of IL-1 action.
Successful completion of these studies will increase our understanding of the role of endogenous IL-1 at
different stages after stroke, determine its therapeutic potential and mechanism(s) of action, and support IL-1
as a promising novel stroke therapy.

Public health relevance
Project Narrative Stroke is a major cause of death and disability worldwide and effective therapies are urgently needed. Emerging evidence suggest that inflammation may play key, potentially beneficial roles in the brain after stroke making it an attractive therapeutic target. We have recently demonstrated that a key inflammatory cytokine, Interleukin-1 alpha (IL-1) promotes angiogenic neurorepair in experimental stroke models, and new results suggest that IL- 1 is also profoundly neuroprotective. In this project, we propose to determine the role of IL-1 after experimental stroke, its therapeutic potential, and mechanism(s) of action with the goal of developing it as a novel stroke therapy.